Inter-organelle communication in lipid metabolism

PROJECT SUMMARY
Atherosclerosis has presented an enormous burden to public health and economy with increasing prevalence.
Cholesterol and triglyceride metabolism play crucial roles in atherogenesis. Genetic, epidemiologic, and clinical
studies have revealed the causal role of LDL in atherosclerosis. The development of LDL-lowering drugs,
including statins and those targeting PCSK9, has greatly improved the prevention and outcome of
atherosclerosis. Despite advances in controlling LDL-C levels, a considerable residual risk remains for
atherosclerotic cardiovascular diseases. In recent years, increasing evidence has linked triglyceride-rich
lipoproteins (TGRLs), in particular VLDL, to atherosclerosis. The liver plays a central role in regulating triglyceride
and cholesterol homeostasis. VLDL is synthesized in hepatocytes and secreted to the circulation. Their
metabolism involves several steps: TG synthesis, lipoprotein particle assembly, intracellular trafficking from the
ER to Golgi and secretion from Golgi. Although we have gained much knowledge about the whole process over
the years, the regulatory mechanisms governing VLDL lipidation and transport from the ER to Golgi have not
been fully understood. VLDL secretion is closely connected to lipid droplet (LD) metabolism. Excess lipids will
be stored in LDs when lipid influx or synthesis surpasses VLDL secretion, while lipids in LDs can be delivered to
apoB for VLDL biogenesis. However, the regulator mechanisms governing these interconnected processes
remain elusive. Our preliminary data suggested that SEC16B, a scaffold protein located at the ER, mediates
both VLDL and LD metabolism in the liver. The overall goal of this proposal is to define the roles of SEC16B in
VLDL and LD metabolism using a series of in vitro and in vivo experiments. Aim 1 will examine how SEC16B
regulates lipid droplets formation in hepatocytes. In Aim 2, we will elucidate the function and mechanisms of
action of SEC16B in VLDL metabolism in the liver. The results of this work will define the novel functions of
SEC16B in VLDL and LD metabolism, and provide insight whether SEC16B could be a novel therapeutic target
for atherosclerosis.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because atherosclerosis, increasing in prevalence, represents a major burden for both public and economy. This study will elucidate the role of SEC16B in modulating lipid droplets and VLDL metabolism, which may unravel potential targets for the intervention of atherosclerosis.